Examining how the novel S64F MAFA variant produces glucose intolerance or hypoglycemia in a sex-dependent manner

PROJECT ABSTRACT
As of 2018, 30.3 million Americans have been diagnosed with diabetes (10% of the U.S. population with a
male sex bias). Its close associations with many chronic diseases, such as heart attacks, strokes, and cancers,
make diabetes a leading risk factor for morbidity and mortality. In all forms of diabetes, the inability to maintain
normal glucose levels results from progressive dysfunction and eventual loss of insulin-producing b-cells in the
pancreas. With high rates of treatment failure on standard therapy, developing new therapeutic approaches to
preserve or even enhance b-cell function is a priority. Furthermore, differences in metabolism between men
and women during healthy aging and disease are appreciated but poorly understood.
Pancreatic b-cells require several key factors to appropriately secrete insulin. One such factor is MafA, a
transcription factor fundamental to mature b-cell function. The early loss of human MafA (MAFA) in b-cells in
patients with type 2 diabetes highlights its importance to human b-cell health. In addition, a naturally occurring,
genetic mutation in MAFA (S64F MAFA) was recently identified to predispose carriers to either familial, adult-
onset diabetes or hypoglycemia (low blood glucose). Curiously, S64F MAFA-associated diabetes is much
more prevalent in men while women tend to present with hypoglycemia. To better understand the sex-
dependent effects of this variant, we generated a mouse model harboring this mutation. This model shows the
expected sex-dependent effects seen in humans, suggesting similar mechanisms between mice and humans.
Male S64F MAFA mice were hyperglycemic due to widespread, premature b-cell aging and senescence, while
female S64F MAFA mice were hypoglycemic by a mechanism which is not yet clearly defined. However, our
preliminary studies suggest that S64F MAFA creates different b-cell subtypes in females, one of which is
hyperfunctional. Taken together, these results suggest that S64F MAFA can incur diverse b-cell responses to
produce sex-dependent diseases: diabetes (b-cell hypofunction) and hypoglycemia (b-cell hyperfunction).
This investigation will identify and compare the diverse molecular responses to S64F MAFA in male and
female b-cells across mice and humans to understand the sex-dependent, b-cell responses unique to human
b-cells. We will first use the penetrant, proof-of-principle S64F MAFA mouse model which mimics several
aspects of human disease to identify the diverse b-cell populations by single cell transcriptomics. For example,
diversity in premature aging signatures will be related to the dysfunction seen in senescent, male S64F MAFA
b-cells. We will then investigate the molecular and functional responses to the S64F MAFA protein in
genetically modified, male and female human b-cells using novel pseudoislet technology to identify targets
unique to human b-cell function. In sum, our work will advance fundamental understanding of sex-dependent
b-cell responses in humans. Mechanisms underlying a relative male vulnerability and female resistance to
diabetes in this model can be harnessed to develop therapies tailored to the individual.

Public health relevance
PROJECT NARRATIVE Diabetes is a leading risk factor for the global burden of disease, and there is an urgent need to better understand this collection of diseases. This proposal aims to define the molecular profile of a subset of diabetes resulting from a human pathogenic variant of MAFA, a fundamental pancreatic islet-enriched transcription factor differentially expressed in mice and humans. These studies will identify β-cell signatures with special emphasis on sex-dependent differences, such as male cellular senescence, in hopes of identifying new therapeutic strategies and targets.